Annual Retreat of the International Society for Environmental Epidemiology

The International Society for Environmental Epidemiology (ISEE) is the preeminent scientific
society focused on relationships between environmental agents and human health. The annual conference provides a critical forum for the exchange of ideas and development of potential solutions to pressing environmental health issues of regional, national, and global significance. It is regularly attended by prominent epidemiologists from academic, industrial, and governmental institutions from around the world. As one of the most important international forums for the presentation of human health research related to air and water pollution, the built environment, and ecosystems supporting food production, it provides a unique opportunity for environmental epidemiologists, regulators, and public health professionals to present their work, cultivate new collaborations, and develop solutions to emerging environmental health issues. Finally, it serves an important training, education, and networking opportunity for junior investigators. Over the next three years, the ISEE annual conference is excited to continue focusing on the effects of environmental exposures on human health, while drawing attention to and addressing ongoing and emerging environmental health issues. Upcoming meetings include: 1) the 35th meeting in Kaohsiung, Taiwan (September 16-21, 2013); 2) the 36th in Santiago, Chile (September 1-5, 2024); and 3) the 37th in Atlanta, Georgia, USA (August 17-24, 2025). The three-and-a-half-day annual meeting offers interdisciplinary examination of new research and methods that are of profound significance to the field of environmental epidemiology. The conference facilitates the exchange of ideas and information between epidemiological investigators and public health practitioners from around the world. The upcoming annual conferences will increase the presence of ISEE in Asia and South America, where environmental exposures are rife, but routinely understudied. Scholarships will be provided to distinguished experts, young investigators, students, and promising scientists from the US and abroad. In turn, this will enhance the global development of environmental health work forces and foster collaborations and exchange
information both nationally and internationally.

Public health relevance
The ISEE annual conference plays a vital role in facilitating dialogue among leading environmental epidemiologists. The conference is the most prominent and comprehensive international gathering of environmental epidemiologists and related environmental health professionals from academia, government, and public health organizations. It provides a forum for discussion, critical review, collaboration, and education concerning environmental agents with the ultimate goal of ameliorating their public health impacts.